Cationic Silyl-lipids for Enhanced Delivery of Anti-viral RNA Therapeutics

PROJECT ABSTRACT
Liposomes, including nucleic acid complexed lipid nanoparticles (LNPs) have shown success in drug
delivery and formulation of sensitive RNA-based therapeutics, including the recent example of the
mRNA Sar-COV-2 vaccine. The goal of this proposal is to synthesize and evaluate novel silyl-containing
lipid structures to access innovative cationic lipid structures representing new chemical space for
biomedical research. Three classes of cationic silyl-lipids will be synthesized in modular fashion to
access structural and conformational cationic lipid analogs that have implications in the phase transition
temperature and the fluidity of the bilayer, influencing the stability, toxicity, and fusogenicity of silyl-
LNPs. This proposal is organized into three specific aims: 1) Synthesis of novel silyl-containing lipids
as diverse cationic lipid vectors using catalytic hydrosilylation methods, particularly focusing on the
modular incorporation of a silyldimethyl group as a bioisostere of a cis carbon–carbon double bond of
known unsaturated cationic lipid vectors, as well as other silyl groups with relevant properties to
modulate the branching and chain length of the resulting lipid. Target molecules include silyl analogs of
DOTMA, DOTAP and DOSPA. 2) Evaluate biophysical properties of liposome formation and silyl-LNP
formulation through established characterization techniques including measurements of zeta potential,
transmission electron microscopy and small-angle X-ray scattering. The RNA/silyl-LNP complex will be
characterized using HPLC to quantify RNA encapsulation. 3) Perform in cellulo studies to provide a
comparative study on transfection efficacy of siRNA and cytotoxicity of silyl-lipid LNPs with commercially
available liposome RNA delivery systems. Overall, our studies aim to demonstrate the potential of
cationic silyl-lipids as novel structures for LNP formulation with the long-term goal to develop novel
delivery systems and improve transfection efficacy of anti-viral RNA therapeutics.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed research is relevant to public health because the design and synthesis of novel cationic lipid structures is critical to improving drug and vaccine delivery systems for biomedical research. As such, the experiments described in this proposal are relevant to the NIH’s mission because they will enable the discovery and demonstrate feasibility of previously inaccessible cationic silyl-lipid molecules with the potential to become new transfection agents and formulations for RNA therapeutics that will enhance health, lengthen life, and reduce illness and disability. The newly developed technology, and the associated lipid nanoparticles, will be expected to benefit chemists and biologists in a variety of disciplines in both academic and industrial laboratories.